GASTRIC, SMALL INTESTINE, AND COLONIC TRANSIT IN MOTOR DISORDER OF GI TRACT

Gastric emptying and small bowel transit will be evaluated in patients with unexplained nausea, vomiting, constipation, and diarrhea by the method of gastrointestinal scintigraphy.